Medicaid coverage of treatment for periodontal disease and its impact on health outcomes

7. PROJECT SUMMARY
This proposal addresses an unmet need in public health by evaluating the role of Medicaid coverage for
treatment of periodontal disease (TPD). Periodontal disease negatively impacts oral health and quality of life.
Prevalent among all adults, periodontal disease is even more common in low-income populations served by
Medicaid, causing tooth loss and dental pain and representing a significant public health challenge. TPD with
scaling and root planing followed by maintenance therapy is the standard of care, but state Medicaid programs
are not obligated to offer dental coverage to adults, leading to considerable inter-state variability in coverage
for TPD. TPD may improve clinical outcomes and be associated with improving control of chronic diseases like
diabetes, but observational data evaluating these effects is considerably confounded. Better evidence is
needed on the relationship between providing coverage for TPD with health outcomes, especially for at-risk
populations like those covered by Medicaid. State Medicaid programs have initiated coverage for TPD at
various times, resulting in a natural experiment that allows us to evaluate the treatment effect of TPD coverage
on both oral and comprehensive health. By leveraging a quasi-experimental design using the comprehensive
source of all Medicaid claims data from 2016 through 2023, the Transformed Medicaid Statistical Information
System (T-MSIS), we will evaluate the effect of implementing Medicaid coverage for TPD across states that
implemented this benefit at discrete points in time, allowing us to isolate the treatment effect of TPD specifically
while accounting for staggered policy adoption and state and time fixed effects. Our first aim is to evaluate the
effect of TPD coverage on tooth loss, emergency department (ED) use for dental problems, and oral
healthcare costs. We hypothesize that coverage for TPD will result in a decrease in tooth loss, ED dental use,
and dental costs among all Medicaid beneficiaries in affected states. Our second aim will evaluate the impact
of TPD coverage on the short-term and long-term complications of diabetes among beneficiaries with diabetes.
We hypothesize a reduction in complications such as hyperglycemic crises, diabetic ulcers, retinopathy, and
nephropathy. The proposed work builds on prior analyses of Medicaid dental benefits by focusing on a specific
procedure with more established implications for comprehensive health, by our use of a novel difference-in-
differences estimator that is robust to the realities of Medicaid dental policy adoption and by incorporating both
oral health and comprehensive health outcomes. Our proposal is of high relevance to Medicaid policymakers
as well as health systems and clinicians by guiding decisions on oral health coverage to improve health in at-
risk populations. Our findings will provide important evidence on the contribution of TPD on the health of
Medicaid beneficiaries and help develop further oral health coverage and interventions for the Medicaid
population.

Public health relevance
8. PROJECT NARRATIVE Periodontal disease is common, affects oral health and quality of life, and may worsen chronic diseases like diabetes. This study will use Medicaid claims data to evaluate the impact of Medicaid dental coverage for the treatment of periodontal disease on rates of tooth loss, emergency department visits for dental problems, and complications of diabetes. Results will help guide Medicaid policy to improve oral and comprehensive health for patients covered by Medicaid.